Targeting ER stress response in B-cell chronic lymphocytic leukemia

Project Summary/Abstract
Chronic lymphocytic leukemia (CLL) is an incurable B cell malignancy that represents 30% of all adult
leukemia. To help combat CLL, we aim to investigate the aggressive behavior of CLL and develop novel
combinatorial therapeutic strategies. Previously, we have shown that the IRE-1/XBP-1s pathway of the
endoplasmic reticulum (ER) stress response is critically important for supporting malignant progression of CLL
in mice. Nevertheless, the factor that drives activation of the IRE-1/XBP-1s pathway in CLL remains unknown.
Clinically, the mutational status of the immunoglobulin heavy chain locus (IgHV) is an important prognostic
indicator for CLL progression and treatment outcome. Human CLL patients with mutated IgHV survive longer
and have a better response to chemotherapy than those with unmutated IgHV. We have recently shown that
aggressive IgHV-unmutated human CLL samples indeed produce significantly higher mRNA levels of XBP-1s
than indolent IgHV-mutated samples. Because this immunoglobulin mutation status is exclusively mediated by
activation-induced cytidine deaminase (AID), we decided to generate an AID-deficient CLL mouse model in
which IgHV could not be mutated. We found that the resultant mice indeed survived significantly shorter than
their AID-proficient counterparts, consistent with the fact that IgHV-unmutated human CLL cells are more
aggressive. Like aggressive IgHV-unmutated human CLL cells, AID-deficient mouse CLL cells also expressed
higher levels of XBP-1s and were more responsive to activation of the B cell receptor (BCR) than their AID-
proficient counterparts. Because AID-deficient CLL cells also produced significantly higher levels of secretory
IgM (sIgM), the largest antibody, than AID-proficient CLL cells, we hypothesized that the increased production
of sIgM in CLL cells is the major factor that drives activation of the IRE-1/XBP-1s pathway to increase the
folding capability of the ER and protect CLL cells from dying of proteotoxicity as a result of accumulations of
misfolded components of sIgM in the ER. We thus propose to genetically delete the capability of producing
sIgM in IgHV-unmutated CLL cells to support our hypothesis. Acknowledging that both XBP-1s and BCR
signaling are significantly upregulated in IgHV-unmutated CLL cells, we propose to investigate whether the
combination of B-I09 (an XBP-1s inhibitor) and a Bruton's tyrosine kinase inhibitor (BTKi) will be more effective
in killing such CLL cells in vivo. Finally, because deleting the capability of B cells in making sIgM will lead to
increased production of secretory IgG (sIgG), we propose to evaluate the roles of sIgG in controlling CLL. Our
goals are summarized in the following specific aims. Aim 1: Establish the roles of sIgM in activating the IRE-
1/XBP-1s pathway to support malignant progression of IgHV-unmutated CLL. Aim 2: Examine whether the
combination of B-I09 and BTKi is more effective in inhibiting the growth of IgHV-unmutated CLL cells that
express higher levels of sIgM and XBP-1s. Aim 3: Examine whether sIgG can enhance the activity of B-I09 or
BTKi in suppressing the growth of IgHV-unmutated CLL in mice.

Public health relevance
Project Narrative Chronic lymphocytic leukemia (CLL) cells activate the IRE-1/XBP-1s pathway of the endoplasmic reticulum stress response to support their growth and survival; however, it remains unclear what activates this pathway in CLL. We propose that secretory IgM (sIgM) is the major factor that activates this pathway and will examine whether sIgM and XBP-1s can serve as biomarkers to predict the treatment outcome of CLL. We will also develop novel therapeutic strategies in which IRE-1/XBP-1s pathway inhibitors or secretory IgG will be combined with Bruton's tyrosine kinase inhibitors to treat the aggressive type of CLL.